COMPUTER SUPPORT TASK ORDERS

The Contractor shall provide task ordered computer support for the maintenance of a large computerized system of chemical, biological, inventory and administrative information for the Developmental Therapeutics Program, Information Technology Branch.